Synthetic Cell State Engineering for Primary Human Cellular Therapies

PROJECT SUMMARY/ABSTRACT
The human genome encodes the unique functional properties of hundreds of different cell types and
states across human development, in health and disease. Complex germline genetic changes over evolutionary
time have given rise to new cell types, and more rapidly similarly complex somatic genetic changes underly the
cell state transformation of cancers. I propose the scientific challenge of whether new therapeutically useful
human cell states can similarly be created through complex synthetic genetic changes of living primary human
cells. To reach the complexity of genetic perturbation required to access potential new synthetic human cell
states, I propose the development and application of two key technical innovations, 1) CRISPR-All, an arbitrarily
combinatorial genetic perturbation platform across perturbation type and scale in primary human cells, and 2)
the combinatorial construction of new, “non-evolved” human genes from existing functional human protein
domains, initially focusing on building new human transcription factors. I will apply these systems in primary
human T cells due to their abundance and thus suitability for large scale screening efforts for the discovery of
synthetic cell states, and the immediate therapeutic relevance of human T cell genetic manipulations for cancer
immunotherapy. Using a tiered screening approach, I will first use CRISPR-All to discover complex combinations
of genetic perturbations and non-evolved, synthetic transcription factors that functionally enhance human T cell
function. Then, using CRISPR-All’s ability to pair arbitrarily complex genetic perturbations with single cell RNA
and ATAC sequencing, I will perform small scale pooled screens with single cell readouts of 100s of functional
candidate complex perturbations and synthetic transcription factors to determine the degree of variance in each
construct’s resulting cell states compared to cell atlases of natural human T cell states. Finally, top candidates
with divergent transcriptomes and chromatin profiles will be characterized through detailed genomic,
mechanistic, computational, and functional analysis to assess whether a stable, therapeutically useful, non-
natural cell state has been accessed. This study is expected to generate new technical platforms for human
cellular engineering, provide greatly expanded insights into the stability of natural human cell states, and suggest
whether the human genome is truly optimal in every cell type in every disease setting, or whether new cell states
can be genetically accessed to tailor the genome of a specific human cell for a specific desired therapeutic
function.

Public health relevance
PROJECT NARRATIVE Human cells are capable of a wonderous diversity of functions in both health and disease, and the various cell states that are naturally accessible can be therapeutically manipulated by drugs, biologics, and increasingly by genetic medicines. But the set of desirable and therapeutically useful functions of human cells may not be confined only to naturally accessible cell states. The proposed research uses a new generalized and arbitrarily combinatorial method for making complex genetic modifications in primary human cells to explore how non- evolved therapeutically useful human cellular states and functions can be generated by constructing new, non- evolved human genes, initially through applications to improve human immune cell function against cancers.